Myeloid Recruitments and their Role in Brain Tumors

PROJECT SUMMARY:
Myeloid cells are one of the most abundant immune infiltrates in the glioblastoma (GBM) tumor microenvironment
(TME); they can constitute 20-30% of the tumor mass and are either of hematopoietic origin or are tissue-
resident. Myeloid cells play a crucial role in shaping the TME, promoting tumor growth, regulating adaptive
immunity, and in response to therapy. Due to these significant roles, myeloid cells are an essential subject of
intensive research and therapeutic target development. However, targeting tumor-associated myeloid cells has
been remarkably challenging. One of the critical factors underlying this difficulty is our incomplete understanding
of their heterogeneity and of the interactions between various myeloid subsets. This application is focused on
myeloid subsets, referred to as monocytes and neutrophils, which infiltrate tumors from the blood circulation and
differentiate into tumor-associated macrophages and tumor-associated neutrophils. We provide evidence that
both populations infiltrate GBM, but that their composition differs; while monocytes are enriched in Proneural
and Classical GBM, Mesenchymal GBM shows increased neutrophils in addition to increased microglia
presence. Using genetically-engineered mouse models driven by human GBM-specific driver mutations, we
discovered that tumor growth was not impaired when the influx of monocytes was abolished in murine Proneural
monocyte-enriched GBM due to compensatory recruitment of neutrophils, which resulted in PN-> MES transition
of tumors. We hypothesize that although monocyte and neutrophil infiltration differ in various GBM subtypes,
they share many common tumor-promoting and immunosuppressive functions. Thus, targeting one population
will lead to infiltration of the other, but targeting both will lead to impaired tumor growth, increased activation of
T-cells, and improved immune surveillance. To address our hypothesis, we will: (1) determine how the spatial
and genetic heterogeneity of GBM affects myeloid infiltration and expression profiles using single-cell RNA-
sequencing, spatial multiomics, and multiplex FACS with a major focus on neutrophils in the presence and
absence of monocyte infiltration. We will functionally characterize myeloid subsets, test their immunosuppressive
properties, and identify how TNFα signaling and/or other neutrophil-driven gliomagens regulate neutrophil-tumor
crosstalk to promote GBM growth in the presence or absence of monocytes; and (2) determine the biological
significance on GBM tumor growth and immunity when infiltration of both myeloid subsets from blood is
abolished. These studies have the potential to help us to understand better the remaining challenges of
macrophage- and chemokine-targeted therapies in cancer. We will also determine the therapeutic efficacy of
two small-molecule inhibitors targeting monocytes and neutrophil influx into tumors.

Public health relevance
Narrative (public health relevance statement): The grim prognosis and lack of therapeutic options for glioblastoma highlight the urgency of working towards developing novel treatment modalities. Myeloid-targeted therapies have been ineffective despite intensive research. This application will provide the unique opportunity to explore myeloid heterogeneity, the mechanisms driving their influx into tumors, and what drives current anti-myeloid targeted therapy resistance.